ECHO Coordinating Center Administration Core

Well-designed research is urgently needed to examine the impact of environmental exposures on health
outcomes in children. To address these knowledge gaps, the Environmental Influences on Child Health
Outcomes (ECHO) program promises to leverage extant pediatric cohorts to test new hypotheses of how
environmental exposures impact pediatric health. The Duke Clinical Research Institute (DCRI) proposes to
serve as the ECHO Coordinating Center (ECHO CC) to provide the organizational framework for the
management, direction, and overall coordination of all common ECHO activities. DCRI is uniquely poised to
lead this ambitious initiative. As the world’s largest academic research organization, DCRI manages nearly 30
active network and administrative coordinating center grants and has emerged as a leader in pediatric clinical
research. In order to provide internal administrative structure for the ECHO CC and ensure appropriate
communication and financial management of the ECHO CC, the DCRI will establish the ECHO
Coordinating Center Administration Component. The Administration Component will provide broad vision
and oversight for the ECHO CC, maintain accountability for all aspects of the ECHO CC, ensure the
implementation of new and innovative, fiscally responsible, ethical approaches to the ECHO research, and
provide guidance for allocation and prioritization of ECHO CC resources.